Investigating the role of memory reactivation during REM sleep for plasticity

Project Summary
Memory reactivation, which occurs during both wakefulness and sleep, is a leading candidate mechanism for
how new information is consolidated to form long-term memories. Influential theories propose complementary
roles for how reactivation benefits consolidation during both non-rapid eye movement (NREM) and rapid eye
movement (REM) sleep—NREM sleep strengthens new memories in cortical networks (systems consolidation)
and REM sleep reorganizes memories within local networks (synaptic plasticity). Over the last two decades,
myriad studies have contributed to our understanding of NREM sleep and systems consolidation. The role of
REM sleep, however, largely remains a mystery, possibly because prior work has not been tuned to detect REM
sleep-dependent memory effects. We propose that REM sleep plays a crucial role in promoting representational
change, specifically by decreasing neural overlap between related memories (differentiation), which reduces
competition during subsequent memory retrievals. We will conduct experiments, complemented by neural
network modeling, to test how competitive learning and memory reactivation during NREM and REM sleep affect
how memories relate to each other in representational space and how much they compete during subsequent
learning and retrieval. Our first aim is to run experiments where we experimentally manipulate levels of
competition during wakeful learning. To track evidence of learning-specific memory reactivation during
subsequent sleep, we will “inject” decodable information into the learning experience and use machine learning
classifiers to distinguish these learning conditions from sleeping EEG brain activity alone. We will use fMRI to
track competitive dynamics and quantify representational change, and demonstrate the behavioral
consequences of this differentiation—less neural overlap should reduce interference and promote new learning.
Our second aim will use computational models to test predictions about how neural representations change
during NREM and REM sleep, and how these changes impact behavior. The model will be tuned using Aim 1
experimental data, and will generate predictions to inform Aim 3 experiments. Our third aim is to run experiments
where we experimentally bias the learning-related content of reactivation during NREM sleep. We will examine
how our NREM reactivation manipulation modulates reactivation during subsequent REM sleep, and whether
REM sleep is necessary for this NREM manipulation to have an effect on memory outcomes. The proposed
studies use a novel combination of state-of-the-art approaches, including: (1) machine learning to decode
memory content from sleeping EEG brain activity; (2) multivariate pattern analysis of fMRI data to track
representational change; (3) behavioral measures sensitive to representational change; (4) neural network
modeling to identify the mechanisms underlying NREM- and REM-related plasticity; and (5) NREM-based
targeted memory reactivation to test how memory processing during NREM and REM sleep interact.

Public health relevance
Project Narrative Approximately 70 million people in the United States suffer from disordered sleep, including people with neurological disorders associated with sleep disturbances. Sleep is critical for learning and memory, and the proposed studies will help us understand underlying mechanisms of these sleep-related memory benefits. Knowing how to target sleep as an intervention to effectively bring about positive memory outcomes could inform public health sleep initiatives and new treatments for memory impairments in clinical populations with sleep disturbances.